Utilizing the Pharmacy Advances Clinical Trials (PACT) Network to Achieve Diversity in COVID Clinical Trials: A Strategic Framework

ABSTRACT/SUMMARY
Drug development and clinical trials have been central to the exponential decline in morbidity and mortality
associated with COVID-19. While disproportionate COVID-19 mortalities have been observed in
underrepresented minority (URM) communities, enrollment into COVID-19 clinical trials has been challenging.
Such challenges have been associated with patient, system, provider, and community barriers, including
mistrust, social determinants of health, failure to meet eligibility criteria, and lack of awareness of studies. To
address these issues, Texas A&M University (TAMU) has partnered with the American Association of Colleges
of Pharmacy (AACP). The primary goals of this project are to employ Artificial Intelligence (AI) and Machine
Learning (ML), develop a national network that would engage innovative strategies, and to train and educate
researchers to advance COVID-19 health equity research in URM communities. TAMU – College of Pharmacy
(COP) has established several outreach program activities designed to educate and enroll URMs in ongoing
clinical trials. The NIH recently funded TAMU-COP to conduct a Moderna COVID-19 Vaccine clinical trial. TAMU
recruited 25% of participants, approximately 35% are classified as URM participants, majority Hispanics.
The long-term goal is to (i) Employ innovative approaches, training, and education methods to increase URM
clinical trial enrollment. (ii) Improve communication strategies and informed messages for URM
populations. The central hypothesis is that the hesitancy of URM participation in clinical trials stems from long-
standing mistrust, lack of culturally competent messaging, lack of access to care, and underrepresentation of
authentic health champions. In addition, community-based pharmacists and pharmacy faculty have a unique role
as community clinical researchers in recruiting URM populations as participants in COVID-19 clinical trials. The
central hypothesis will be tested via the following two aims: Aim 1: Leverage Artificial Intelligence and
Machine Learning to enable environmental scans in target communities to optimize URM participation
in COVID-19 clinical trials. Aim 2: Create and train a network of community-based investigators,
pharmacists, and other partners to directly increase clinical trials participation among URM
populations. These aims will be pursued via innovative AI/ML analytics, training, education, and community
network. The immediate expected outcomes will be a better understanding of the critical elements of COVID-
19 clinical trials hesitancy in URMs and effective interventions for addressing hesitancy. It is anticipated the
proposed interventions will positively impact enrollment in clinical trials.

Public health relevance
PROJECT NARRATIVE The proposal seeks to address the lack of participation in COVID-19 clinical trials by underrepresented minorities (URMs). The objective will be to identify barriers and assess unmet needs of URMs in clinical trials via Artificial Intelligence and Machine Learning (AI-ML) analytics and gain trust within URM communities through micro-influencers and key community leaders at key community centers and pharmacies via culturally authentic messaging. Texas A&M University has partnered with the American Associations of Colleges of Pharmacy (ACCP) to develop the 'Pharmacy Advances Clinical Trials' (PACT) Network to Achieve Diversity in COVID Clinical Trials at URM communities.